Prehospital Activation of ED Teams to Improve Sepsis Care

PROJECT SUMMARY/ABSTRACT
Support from this Mentored Career Development Award will provide Ithan Peltan, MD, MSc the additional skills
and training he needs to succeed in his goal of becoming an independent physician-scientist focused on
improving early sepsis care. Dr. Peltan is a board-certified pulmonary and critical care physician at
Intermountain Healthcare with a track record of research success, proven dedication to clinical investigation,
and an excellent foundation in methods for high-quality clinical research. This proposal will complete Dr.
Peltan’s transition to research independence via a structured career development plan that builds on his prior
training and experience and leverages an environment with rich research and career development resources
as well as access to granular multicenter clinical data. Specific learning objectives include (1) advanced
epidemiologic and biostatistical methods; (2) implementation science and associated methodologies; and (3)
the design and conduct of clinical trials. Dr. Peltan will acquire these new skills and knowledge by means of
formal coursework, professional development training, and an innovative program of mentored research that
will advance medical knowledge about sepsis and identify strategies to facilitate delivery of high-quality sepsis
care in the emergency department. Dr. Peltan’s career development will be guided by an experienced and
cohesive multidisciplinary mentorship team with expertise in critical care, emergency and prehospital research,
sepsis, implementation science, clinical trials, and advanced analytic methods.
Sepsis causes or complicates hospital stays for over 1 million U.S. patients every year, with mortality of 15-
20%. Early, appropriate antibiotics are critical to optimal sepsis outcomes. Many patients who present to the
emergency department (ED) with sepsis, however, do not receive antibiotics within the intervals recommended
by international guidelines and required under government standards. Given the barriers to accomplishing
timely antibiotics using current care models, new approaches to ED sepsis care are urgently needed. The
research planned for this K23 award aims to (1) validate methods to identify patients likely to have sepsis at or
before ED arrival and (2) understand the unintended consequences of care systems that prioritize rapid
antibiotic imitation for sepsis in order to (3) test whether redesigning ED sepsis care around multidisciplinary
“Code Sepsis” teams activated on or before patient’s ED arrival could improve delivery of high-quality sepsis
care. Importantly, this proposal addresses questions and develops methods applicable to care delivery for
other high-risk critical illnesses. Findings from this research will provide the preliminary data for R01 or
equivalent funding to support a multicenter cluster-randomized trial of the Code Sepsis protocol.

Public health relevance
PROJECT NARRATIVE Sepsis, the combination of infection and acute organ failure, affects more than one million people every year in the United States, kills at least 15-20% of its victims, and costs the U.S. healthcare system nearly $24 billion in the process. Early administration of appropriate antibiotics improves sepsis outcomes but faces logistic, cognitive, and organizational barriers, especially in the emergency department, where most sepsis patients receive their first substantive evaluation and treatment. Findings from this study will aid the development and implementation of systems for emergency department sepsis care that can dramatically expedite evaluation and treatment initiation while minimizing unintended consequences.